Mechanisms of REST-mediated immunosuppression in cancer

Project Abstract
Tumor-intrinsic factors in cancer cells modulate the immune milieu to enable prolonged survival and growth of
tumors. In breast cancer (BC), the 2nd leading cause of cancer-related deaths in women, molecular subtyping of
these factors effectively guides targeted therapies, but does not guide immunotherapy approaches as immune
infiltrates vary significantly within each subtype. The presence of tumor-infiltrating lymphocytes (TILs) is highly
prognostic for survival and therapeutic benefit in BC, but the tumor-intrinsic factors governing their presence are
not well defined. Using TCGA RNA analysis, I have identified loss of function in the transcriptional repressor
REST as being a key correlate to reduced lymphocyte infiltration into tumors of multiple BC molecular subtypes.
Loss of functional REST in BC (~15-20% of tumors) is associated with poorer prognoses, however, the
mechanisms by which loss of REST function modulates the tumor immune microenvironment are not known and
may provide novel targets for enhancing therapeutic responses. I recently generated a murine Rest knockout
BC line (Rest-less) and my in vivo studies confirmed that Rest-less tumors contain significantly less lymphocytes
while also revealing a significant increase in pro-tumor macrophages, a cell population our lab has identified as
being key modulators of lymphocyte suppression in BC. Furthermore, my in vitro studies identified
lymphangiogenic Vegfc and Vegfd among the most differentially upregulated genes in Rest-less BC cells. Tumor
lymphangiogenesis is linked to T cell suppression in solid tumors and may provide a reason for Rest-mediated
suppression of lymphocytes. Based on my preliminary data, I hypothesize that lymphocyte suppression in Rest-
less tumors is orchestrated by the polarization of tumor-associated macrophages (TAMs) and lymphatic
endothelium to a suppressive phenotype. I propose two specific aims to test my hypothesis. In Aim 1, I will
determine the role of tumor intrinsic Rest on TAM-mediated lymphocyte suppression using co-culture assays of
TAMs from Rest-less tumors together with lymphocytes in vitro and macrophage depletion through anti-CSF-1R
treatment in an antigen-specific (GFP; JEDI) Rest-less model in vivo. In Aim 2, I will evaluate how Vegfr3, the
receptor for Vegfc and Vegfd, regulates the REST-less tumor microenvironment and responsiveness to
immunotherapy. To accomplish this task, I will test anti-Vegfr3 blockade on Rest-less tumors with or without anti-
PD1 and comprehensively analyze tumor growth, lymphatic depletion, and immune responses using RNAseq,
spectral cytometry, and cyclic immunofluorescence. Our proposed research will provide an understanding of a
previously uncharacterized facet of REST-mediated immune suppression in BC and will use novel murine
orthotopic models to test strategies that block immune suppressive mechanisms. Ultimately, I anticipate my
findings will reveal targetable mechanism(s) to inhibit Rest-mediated immunosuppression in BC and provide a
considerable impact on the treatment of REST-less tumors overall.

Public health relevance
Project Narrative Current immunotherapeutic approaches largely fail to improve survival for patients with breast cancer, the second-leading cause of cancer related deaths of women in the United States. Completion of this research proposal will advance our understanding of how loss of tumor-intrinsic REST function, found in 15-20% of breast cancers, promotes an immune suppressive tumor microenvironment, which may, in part, promote resistance to immunotherapy. Information gained from these studies will provide targetable mechanisms to increase sensitivity to immunotherapies in REST-less breast cancer with the potential to inform treatment strategy for other REST- less tumor types.